Anti-CRISPR-mediated Acylation and Bioreversible Esterification for Precision Genome Editing

PROJECT SUMMARY/ABSTRACT
Clustered regularly interspaced short palindromic repeats (CRISPR)/CRISPR-associated (Cas) systems use
RNA-guided proteins (e.g., Cas9, Cas12a) to cleave DNA. Cas9 and Cas12a share many similarities and have
been repurposed for genome editing in human cells because of their programmability, simplicity, and
efficiency, with applications in basic research and medicine. Cas12a is generally more efficient and specific
than Cas9. However, since the concentration of Cas protein is much higher than that of the DNA target in
genome editing, prolonged Cas12a activity also leads to off-target DNA cleavage, chromosomal translocations,
and genotoxicity.
Equipping Cas12a with an “on-off” switch can overcome these challenges by shortening Cas12a’s window of
exposure and increasing its specificity—the on-target to off-target ratio of DNA cleavage. We developed a
novel strategy that repurposes a CRISPR-Cas inhibitor protein (i.e., an anti-CRISPR) to selectively acylate or
“cage” Cas12a with a small-molecule-removable group. We propose to deliver small molecules and anti-
CRISPR proteins into human cells via fast, bioreversible, and in vivo-compatible means to activate and
inactivate Cas12a, respectively, and increase its specificity. With the help of experts at the outstanding MIT
and Broad Institute facilities, I will learn how to use liquid chromatography–tandem mass spectrometry
(LC–MS/MS) to assess the selectivity of our novel Cas12a acylation strategy, and mammalian cell culture, high
throughput confocal microscopy, next-generation sequencing, and computational analysis to assess
anti-CRISPR delivery and Cas12a genome-editing specificity. Overall, this research will introduce the first
approach for the site-selective and reversible acylation of Cas12a lysine residues and a new bioreversible
esterification strategy for the traceless delivery of anti-CRISPR proteins that together will increase genome-
editing specificity.

Public health relevance
PROJECT NARRATIVE Since the concentration of CRISPR-Cas protein is much higher than that of the DNA target in genome editing, prolonged exposure of human cells to Cas12a leads to off-target DNA cleavage, limiting therapeutic applications. Equipping Cas12a with an “on-off” switch can address this problem, but current strategies require the viral delivery of unstable Cas12a-fusions or use electroporation-based delivery methods unsuitable for in vivo genome-editing applications. This project combines a novel, site-selective lysine acylation strategy with bioreversible, non-viral delivery to develop a triggerable Cas12a ribonucleoprotein that is suitable for in vivo genome editing.